TRIO Professional Development Core

The North Carolina Kidney, Urology, and Hematology Training, Research, Innovation, and Outreach
Program (henceforth referred to as TRIO) aims to create an innovative, integrated, interactive and diverse
training and mentoring program in KUH diseases. The goal of the Professional Development Core is to provide
a rich menu of professional growth opportunities that have been individualized into a tailored curriculum for our
trainees, and also to create a pipeline of skilled mentors. We plan to do this by (a) fostering diverse, interactive,
and multidisciplinary professional development programming for KUH scholars across the continuum of their
careers. This would include new KUH-specific professional development opportunities such as the biweekly
Town Halls, mini-symposia and TRIO-Track Panels (career path opportunities), and also close interactions with
our three CTSAs to leverage existing opportunities for the benefit of our KUH trainees; (b) creating an Individual
Development Plan (IDP) for each trainee that serves as a real-time training guide; and (c) building a pipeline of
mentors across the continuum of KUH scholars, using interactive learning and evidence-based mentorship
training that emphasizes the benefits of justice, equity, diversity, and inclusivity for both trainees and mentors.
In summary, the Professional Development Core will expose trainees to an array of exciting opportunities in the
broad field of KUH; provide collective and individualized training that enhances foundational skills and expands
scientific and clinical depth and breadth; and mentor the mentors since great mentors are not born great mentors,
rather they have been mentored themselves to become inspiring role model teachers and counselors. This will
collectively result in an ever-expanding array of resources that realistically inspires and propels the trainee to
“shoot for the stars.”